Exploring super charged NK cells as a novel cell-based immune therapy in targeting platinum resistant ovarian cancers

Women diagnosed with high grade serous ovarian cancers (HGSOCs) often suffer from disease relapse that is
resistant to platinum-based chemotherapy. Effective treatments are needed as patients often die soon after.
Chemoresistant tumors are enriched with poorly differentiated stem-like cells (PD-SLCs) that harbor unique traits
such as expression of stemness-related genes, enhanced DNA repair, and reduced expression of MHC class I
which allows them to escape chemotherapy and cytotoxic T-cells. For successful eradication of chemoresistant
HGSOC tumors it is imperative to get rid of both differentiated tumor cells as well as PD-SLCs. Natural killer
(NK) cells are innate immune cells that mediate strong cytotoxicity against PD-SLCs particularly those
expressing low levels of MHC class I. But endogenous NK cells are few in number and defective in many cancer
patients including women diagnosed with HGSOCs. To address this clinical challenge, our group has developed
a novel ex vivo platform that can expand and activate NK cells-coined super charged (sNK) cells for allogenic
cell therapy. These NK cells can be expanded exponentially and are not only durable but also functionally
superior to peripheral blood NK cells. In addition, unlike T cells sNK cells do not mediate GVHD or cause cytokine
storm syndrome. Together these qualities make these cells a powerful tool in targeting solid malignancies. Our
work demonstrates that ovarian tumors enriched with a poorly differentiated phenotype can be directly targeted
by sNK cells. In response to secreted cytokines by the sNK cells any remaining tumor cells become more
differentiated and readily targetable with chemotherapy. These findings provide a strong rationale for testing the
efficacy of sNK cells, alone and in combination with carboplatin in targeting platinum resistant HGSOCs. We
hypothesize that our proposed therapeutic sNK cells in combination with carboplatin will be more effective in
targeting platinum resistant HGSOCs enriched with PD-SLCs. To test this hypothesis, we will first test the efficacy of
sNK cells, alone and in combination with carboplatin in targeting a large panel of primary chemo resistant HGSOC
tumors in vitro and patient-derived xenografts (PDXs) in vivo. This will help us understand the applicability of our
proposed therapeutic in a large number of patients with advanced HGSOCs. To investigate the potential biomarkers
of response to sNK cells, we will perform single cell profiling of tumor cells at the RNA and protein level using scRNA
seq and CyTOF to delineate the expression level of genes and gene sets associated with susceptibility to sNK cells.
Top ranking pathways here include MHC class I and stemness associated genes. These findings can help guide
selection of patients who may most benefit from this treatment in future clinical trials. We will also explore the
underlying mechanism that regulate the antitumor activity of sNK cells and carboplatin combination in targeting the
chemoresistant HGSOC tumors. Our focus will be to decipher the roles of TNFα and IFNγ secreted by sNK cells in
driving tumor cell differentiation and chemosensitization. Overall, findings from this proposed study may provide an
immediately applicable treatment option for women Veterans impacted with HGSOCs.

Public health relevance
Emergence of chemoresistant disease enriched with poorly differentiated stem-like cells that escape chemotherapy and T immune cells is a leading cause of death in ovarian cancer (OC) patients. Our data suggests that these tumor cells can be attacked by another immune cell type called Natural Killer (NK) cells. Unfortunately, NK cells are defective and low in number in OC patients. To solve this problem our group has developed a novel platform that can activate and expand NK cells at clinically scalable levels for immunotherapy, called super charged NK (sNK) cells. In this study we will test the efficacy of sNK cells, alone and in combination with chemotherapy in targeting chemoresistant OCs. Biomarkers of response and mechanisms of tumor targeting will also be explored. Findings will have immediate potential for translation into therapies for women Veterans.